Role of canonical and non-canonical beta-catenin signaling in HIV-1 latency

PROJECT SUMMARY/ABSTRACT
HIV remains an incurable infectious disease due to establishing a subset of latently infected reservoir
cells. HIV latent cells are not eradicated by immune systems or combination antiviral therapy (cART) by
regulating viral RNA transcription and subsequent protein translations. The long-lived central memory CD4+ T
cell subset (TCM) is regarded as the predominant HIV reservoir. Latency reversal agents (LRAs) reactivate
dormant viral gene expression, following HIV clearance by immune response or cART. However, the current
LRAs have failed to reduce the reservoir size in the clinical trial due to the heterogeneous mechanisms in HIV
latency. In addition, LRAs negatively affect immune function. The long-term goal for this research is the
identification of alternative pharmaceutical targets to universally influence reverse latency and immune
response for HIV functional cure.
The Wnt/β-catenin pathway restricts HIV replication and is also involved in HIV latency by promoting
self-renewal and proliferation of TCM, while β-catenin is not being explored for HIV latency reversal. The Wnt
signal translocates β-catenin to the nucleus that forms a canonical transcriptional complex with the TCF/LEF
transcription factors to induce downstream gene expressions (canonical β-catenin signaling). Recently,
Interactions of β-catenin with other transcription factors, FOX family proteins, have also been reported, which
regulates gene expression independently of canonical β-catenin signaling (non-canonical β-catenin
signaling).
The rationale of this proposal is based on the previous reports and our preliminary data that 1)
inhibition of β-catenin with TCF/LEF complex reactivated HIV latent T cells and immune stimulations, and 2)
synergistic latency reversal effect was observed with the HDAC inhibitor by β-catenin attenuation. The
objective of this study is to reveal the role of β-catenin signaling pathways in latently infected T cells. The
central hypothesis is that the non-canonical β-catenin signaling allows latency reactivation and stimulates
immune cell function, which will aid in the design of new strategies for HIV eradication. The objective of this
project will be accomplished by three specific aims with a team of undergraduate researchers: 1) Evaluation
of non-canonical β-catenin signaling in HIV latency 2) Elucidation of synergistic interaction between LRAs and
β-catenin signaling, and 3) Assessment of β-catenin non-canonical signaling in immune activation.
The significance of this study is not only finding the novel pathway to let viruses released from latency
but also creating a synergistic effect with other LRAs and being an immunostimulant for the subsequent
reactivated cell clearance that makes innovation in the successive combination LRA therapy.

Public health relevance
Project Narrative HIV is a globally epidemic virus that infects the immune cells and subsequently leads to acquired immunodeficiency syndrome. Although combination antiviral therapy efficiently suppresses HIV replication below the detection limits, a functional HIV cure has not been achieved due to a persistent reservoir formation within immune cells. This project is conducted in order to identify novel strategies for viral reactivation and subsequent eradication of HIV-infected cells.